Time Use Across the Life Course: Family Inequality and Multigenerational Well-Being

Project Summary
This continuing application requests five years of support for three in-person and two virtual
conferences on time use, family inequality, and well-being. The application builds on the 2018
and 2020/1 conferences supported by NICHD and the sixteen-year history of successful time
use conferences sponsored by the Maryland Population Research Center. Proposed
conferences are critical venues for advancing knowledge and developing a diverse research
community who have expertise in time use, family inequality, and well-being over contexts and
groups. Facilitating research how COVID-19 has affected daily behaviors, interactions, and well-
being is an urgent new need. There are also critical needs to advance knowledge on
underexplored topics, including time as a pathway for racial-ethnic differences in time use and
health and time use as a social determinant of health across life stages and contexts. Building
the research community and facilitating innovative research on daily behaviors (parenting, food
behaviors, physical activity, sleep), social interactions, and life experiences (well-being), which
are key pathways between social factors and health, is needed to address persistent and
emerging individual and population health disparities. The aims of the proposal are to 1) provide
a forum for interdisciplinary research and dialogue by showcasing exemplary research and
providing opportunities to engage with and develop innovative interdisciplinary research on time
use and population health disparities; 2) identify underexplored and emerging issues in time use
research by providing an inclusive environment to surface and target critical gaps in knowledge
on time use, health, and well-being; 3) facilitate high-impact time use research and publications
by providing opportunities to form collaborative research projects and facilitate effective policy
communication on ways to apply time use and health research knowledge to improve
effectiveness and scope of public policies and programs; 4) expand and support the research
community by developing interest and expertise in using time use data to answer crucial
questions about the health and well-being of families and children among diverse scholars and
enhance substantive and methodological expertise among early career scholars from
underrepresented groups to cultivate the next generation of time use researchers. To address
these aims, the proposed conferences will provide a high-profile platform for innovative research
and methodological approaches and facilitate scientifically rigorous, policy-relevant research on
these topics across the life course, over time, and across policy contexts.

Public health relevance
Narrative Proposed conferences are critical venues for shared work and dialogue and development of diverse scholars with expertise in time use, family inequality, and well-being over contexts and groups. Facilitating research how COVID-19 has affected daily behaviors, interactions, and well- being is an urgent new need. There are also critical needs to advance knowledge on underexplored topics, including time as a pathway for racial-ethnic differences in time use and health and time use as a social determinant of health across life stages and contexts.